Surface Induced Epithelial Differentiation Improves Percutaneous Device Longevity

Project Summary: Percutaneous devices are often utilized in medicine and serve as a bridge between the
internal and external bodily environments. Dental implants, bone-anchored hearing aids, and percutaneous
osseointegrated (OI) devices for amputees are just a few examples. Although widely used, the soft tissue
interface (in particularly, the epidermis) with these devices commonly fails to heal properly and disintegrates
over time. It is known that immediately following percutaneous implantation; epidermal cells migrate proximally
along the implant surface in an attempt to heal the surgically-created soft tissue defect. This phenomenon,
termed "epidermal downgrowth," creates a sinus tract around the implant and provides a nidus for bacterial
colonization. To improve patient outcomes, our previously funded PRORP study investigated the relationship
between crystallinity and coating stability of fluoridated apatites. The data revealed that sintered fluorapatite
(FA) possessed the ability to enhance epidermal adhesion and differentiation—a transition highly crucial for
preserving the integrity of soft tissue attachment at the implant exit-site—when compared to the current
standards of practice, titanium. These data further revealed that osteoblasts and fibroblasts also have affinities
to this treated apatite surface, implicating a possible wider application of these apatites for promoting
osseointegration as well as skin integration. FA coatings are not currently used in percutaneous
osseointegrated (OI) device applications, and thus considered novel. It was believed that commercial
technologies that use high temperatures for vaporizing the coating materials might not be suitable for
maintaining the optimized crystallinity found within the sintered FA agglomerates. Thus, we used a low-
temperature proprietary coating technique, IonTite™, which worked well in initial animal trials in rats and pigs.
The overall goal of this proposal is to undertake safe and efficacious testing of this coating in a weight-bearing
large animal model prior to assessing its clinical and commercialization potentials. To this end, we
hypothesized that epidermally mediated downgrowth, osseointegration and healing outcomes around
the percutaneous OI devices would be improved by coating the devices with a bioactive, fluorapatite
sintered at 1150°C. Aim 1 will establish an ideal, low temperature, commercial coating technique for applying
FA to titanium surfaces. Aim 2 will determine the efficacy of the FA-coated percutaneous OI devices to prevent
epidermal downgrowth and to accelerate osseointegration in a weight-bearing large animal model. Aim 3 will
confirm the completion of wound healing cascades within the periprosthetic tissue of FA-coated devices by
molecular means. The outcome of this proposed study will have immediate clinical applications for the design
of both permanent and temporary percutaneous implants. This proposed technology will permit current
amputee patient populations, who are suffering from life-long complications associated with the stump-socket
interface, to be fitted with the FA-coated percutaneous OI prostheses.

Public health relevance
Project Narrative: Percutaneous osseointegrated (OI) devices are becoming a viable alternative to socket suspension of artificial limbs. Although patient satisfaction with this device is high, the weaker link is the vulnerable epidermis-to-implant interface, where interfacial epidermis grows down uncontrollably and produces a sinus tract. Literature indicates that percutaneous healing may be directly related to the biocompatibility of the device material, and importantly, the epidermal adhesion and proliferative patterns. The lack of epidermal integration with the device keeps the interfacial epidermal cells in a migrative phenotype. It is believed that the key for preventing epidermally mediated downgrowth is to use surfaces that promote epidermal cells to form adhesion with them. Our in vitro and non-weight bearing animal studies data indicated that sintered fluorapatite (FA) surfaces could induce such adhesion and differentiation of keratinocytes. Thus, this study proposes to test this unique FA-coated surface in a weight-bearing animal model before the clinical introduction.